STRUCTURE AND FUNCTION OF THE INSULIN RECEPTOR

The aims of the research proposed here are to study the structure of the insulin receptor and the mechanism by which insulin activates membrane transport systems, in particular the (NA+, K+) ATPase and other Na+ transporters. One aim is to identify functional domains of the insulin receptor involved in monomer-monomer interactions, disulfide bond formation and insulin binding. Another aim is to determine and isolate the components involved in transducing the signal of the insulin receptor interaction to the (Na+, K+) ATPase and other Na+ transporters.